CHRONIC FLOLAN INFUSIONS IN PATIENTS WITH SEVERE PRIMARY PULMONARY HYPERTENSION

We believe that vasoreactivity with acute challenge of potent IV vasodilators will predict long term oral vasodilator therapy success in patients with pulmonary hypertension. We wish to establish to what extent pulmonary hypertension is amenable to chronic vasodilator therapy and to determine which therapy is effective. We are interested in adding any new knowledge to our understanding of the etiology.